Patient-tailored network prediction of neurodegenerative disease progression

PROJECT SUMMARY/ABSTRACT
This is an application for a K01 award for Dr. Jesse Brown, a postdoctoral scholar in clinical neuroimaging at the
University of California, San Francisco (UCSF) in the Memory and Aging Center (MAC). Dr. Brown is an early-
career neuroscientist focusing on brain network neuroanatomy involved in neurodegenerative disease. This K01
award will provide Dr. Brown with the support necessary to accomplish the following goals: 1) gain experience
in the network neuroanatomy of dementia, 2) achieve proficiency in PET data analysis with an emphasis on tau
imaging, 3) become an expert in longitudinal statistical modeling, 4) expand knowledge of new MRI neuroimaging
methods, and 5) develop an independent research career. To achieve these goals, Dr. Brown has assembled a
mentorship team including a primary mentor, Dr. William Seeley, a behavioral neurologist who conducts
neuroimaging and neuropathological studies on selective regional vulnerability in neurodegenerative disease; a
co-mentor, Dr. Gil Rabinovici, a behavioral neurologist who investigates how molecular brain imaging techniques
can be used to improve diagnostic accuracy in dementia; a collaborator, Dr. Howard Rosen, a behavioral
neurologist who uses neuroimaging to track how neurodegenerative diseases affect the brain over time; a
collaborator, Dr. John Kornak, a biostatistician who is an expert in longitudinal data analysis; and a collaborator,
Dr. Christopher Hess, a neuroradiologist focused on the translational application of MR imaging techniques to
brain degeneration. This proposal describes a multimodal neuroimaging approach to predict neurodegenerative
disease progression in individual patients with frontotemporal dementia (FTD) and Alzheimer's disease (AD).
The central hypothesis of this proposal is that each of these diseases originates in a selectively vulnerable brain
region or “epicenter” and spreads outwards along network connections, with affected regions first showing
elevated tau protein binding, followed by an increased rate of gray matter loss, and eventually a high degree of
cumulative atrophy. We will first develop methods to detect patient-tailored epicenters in FTD/AD patients with
different clinical syndromes and use clustering methods to identify atrophy subtypes (Aim 1). We will then test a
model predicting that as disease spreads from an epicenter throughout the network, nodes that become affected
will show a greater longitudinal rate of atrophy before they show high cumulative atrophy (Aim 2). Finally, in an
updated Aim 3, we will use 18F-AV1451 PET imaging to test whether spatial patterns of cross-sectional tau and
longitudinal atrophy in AD are more accurately predicted by region-autonomous growth than by connectivity-
based spread. The goal of this project is to improve prognostic accuracy in individual dementia patients. This
proposal includes innovative imaging and statistical methods that will help us evaluate different biomarkers of
network-based neurodegenerative disease progression in a clinical trial. The K01 training will prepare Dr. Brown
to build translational neuroimaging tools enabling next-generation monitoring of brain disease.

Public health relevance
PROJECT NARRATIVE We currently lack patient-tailored predictions of how neurodegenerative disease will spread in the brain. We now have the tools to design a better predictive model of disease progression which will yield more accurate personalized prognosis about cognitive decline, better inform targeted interventions for slowing disease progression, and tell clinicians where in the brain to look for signs of preservation in clinical trial treatments.